Translational Research Support Core

PROJECT SUMMARY/ABSTRACT – TRANSLATIONAL RESEARCH SUPPORT CORE
The Translational Research Support Core (TRSC) facilitates multi-directional, translational
research by expanding translational partnerships, developing and enhancing research
resources to provide to Center personnel, and advancing the CHHE engagement mission. The
TRSC is co-directed by experienced experts in clinical research and data science, with a record
of success in fostering and maintaining productive collaborations. The organizational division
into Translational Partnerships and Translational Resources reflects the need to (i) cultivate
relationships and connect basic and clinical investigators, and (ii) connect investigators to
resources and provide direct support to collaborative partnerships, to spur new discoveries and
provide translational opportunities. Existing Translational Partnerships with the Brody School
of Medicine at East Carolina University, NC Central University, and NC Department of Health
and Human Services continue to provide access to clinical laboratory services, tissue biobanks,
statewide exposure databases, health disparities research resources, and public health and
clinical researchers and patient populations. A partnership with the NC Area Health Education
Center will allow the CHHE to translate research findings into Continuing Professional
Development programming for health care providers. The work of the TRSC will continue to be
informed by joint activities with the CEC, including participation in the CEC Stakeholder
Advisory Board meetings. The Translational Resources include Human Study Support, the
Environmental Data Science Group (EDSG), and Community Engagement. Newer human study
resources such as the exposure cohorts NEST, STRIVE, and the GenX study, represent
emerging ecosystems, and the role of the study principal investigators (themselves TRSC
members) is to serve as expert guides and to evaluate collaborative opportunities with CHHE
members. This increased collaborative resource activity will require additional data
management expertise and assistance with resource sharing/public repositories provided by
the CHHE Data Manager. EDSG evolution has been driven by (i) continued explosive growth in
-omics/sequence technologies that are transforming the EHS landscape, (ii) an increased need
for general expertise in study design and analysis, (iii) an increased need to connect
investigators with curated and public data sources such as Comparative Toxicogenomics
Database (CTD), All of Us, and GTEx, that can be used for insilico follow-up, and (iv) novel
statistical methods development as needed. The EDSG is configured to maximize the
translational impact of CHHE activities by ensuring that data and findings are handled
according to FAIR (Findable, Accessible, Interoperable, Reusable) principles. The EDSG will
continue to use the request tracking system, provide augmented services, assist with data
management and sharing in public repositories and coordinate training and custom curation
opportunities with the CTD.